Career Enhancement Program

PROJECT SUMMARY/ABSTRACT – Career Enhancement Program (CEP)
The central mission of the UCLA SPORE in Brain Cancer is to stimulate, recruit, develop, and retain new
investigators in the field of brain tumor research, with particular focus on translation of scientific discoveries to
novel clinical applications. The future of brain tumor research lies in the continued creation and development
of translational projects and innovative investigators at major research institutions, as well as an institutional
commitment to support outstanding, dedicated scientists in the field. In order for translational scientists and
physician-investigators to grow and flourish, funding support and peer mentorship is imperative. The UCLA
SPORE in Brain Cancer Career Enhancement Program (CEP) will provide this research support and mentoring
resource, allowing junior faculty to transition to independent investigator status with adequate peer-reviewed
funding and established investigators to focus or redirect their research to the area of brain cancer. CEP funds
will be designated to prepare investigators for careers in translational brain cancer research and enhance their
chances of success in the field. Applications will be accepted from MD, PhD, or MD/PhD advanced post-
doctoral fellows who are ready to transition to a faculty position within one year or junior faculty who will work
with established investigators and senior mentors in the brain cancer research field. Special efforts will be
made to recruit qualified women, individuals from underrepresented racial and ethnic groups, as well as
individuals with disabilities. Applications will be reviewed by the CEP Selection Committee, IAB and EAB
members, and ad hoc reviewers with particular areas of expertise relevant to the applications. Each year, we
anticipate supporting 2 to 3 highly innovative candidates with CEP funds at a minimum of $50,000 each.
Ultimately, the CEP is designed to increase scientific inquiry and excellence across the continuum of research
on the prevention, early detection, diagnosis and novel therapies for brain cancer.